Uncovering mechanisms of complex tissue assembly using dental organoids

The tooth is a complex organ comprised of molecularly and structurally diverse soft and mineralized tissues.
Challenges in regenerating the tooth root lie in simultaneously rebuilding these unique tissues in a spatially-
organized manner. Furthermore, sensory innervation and proper attachment to surrounding healthy alveolar
bone is critical for regenerated dental tissue function. Carefully orchestrated spatial and temporal cues regulate
tissue patterning of the tooth during development and ensure that the tooth and its supporting tissues are
integrated into the jaw. Understanding these processes during repair will advance the field of regenerative
dentistry. Using scaffold-free tissue engineering approaches, we have generated tooth root organoids using
dental pulp stem/progenitor cells (DPSCs) and periodontal ligament (PDL) stem/progenitor cells (PDLSCs).
These organoids comprise a striated structure of mineralized and unmineralized tissues, with a central pulp-
like tissue enclosed within a mineralized dentino/cementogenic tissue surrounded by a soft periodontal
ligament (PDL)-like tissue. Building this type of complex construct containing multiple, anatomically organized
tissues with hugely varying structural, biochemical, and mechanical properties is a significant challenge in field
of tissue engineering. Here, we propose utilizing tooth root organoids as novel 3D experimental models to
define stages of DPSC and PDLSC fate that are critical for reparative tissue assembly and integration. In Aim
1, first, a time course evaluation will be performed to histologically map stages of cell fate and the progression
of tissue assembly in tooth root organoids. Then, single cell transcriptomic analysis will be conducted to track
the trajectories of cell differentiation and comprehensively define the cell populations comprising the organoids.
The goal of Aim 2 is to uncover mechanisms regulating innervation of dental organoids. During natural tooth
development, innervation is a tightly regulated spatiotemporal process. Here, we will investigate if dental
stem/progenitor cells recapitulate these developmental phenomena while assembling dental organoids. In Aim
3, the ability of tooth root organoids to form physiological attachments to bone will be evaluated. Proper
attachment of repaired or regenerated dental tissues to the alveolar bone remains a major clinical challenge.
Tooth root organoids will be orthotopically implanted into healed tooth extraction sites in rats. Histological and
microcomputed tomography analyses will be used to determine if the tooth root organoids are able to maintain
their patterning and form Sharpey’s fibers to attach to the bone. In addition, the ability of these engineered
dental tissues to become vascular and innervated in vivo will be assessed. The completion of this proposal will
result in new knowledge on mechanisms governing tissue patterning in engineered tissues. This study will also
provide important information on factors driving functional integration of regenerated tissue with the body. The
outcomes of this work can be translated into developing new effective dental therapies and applied to
regenerating organs throughout the body.

Public health relevance
PROJECT NARRATIVE Engineering full organs that can functionally integrate with the body is a major challenge in regenerative medicine. In this study, we are developing methods to tissue engineer complex dental structures and discovering mechanisms driving their integration with healthy tissues, specifically investigating innervation and anatomical bone attachment. This study will lead to new effective dental therapies and translate to improving regeneration and integration of organ systems throughout the body.